Decoding the polymicrobial interactions in bile acid metabolism by the gut microbiome.

Abstract
The complex interplay between the gut microbiome and the host is mediated by the constant exchange
of macromolecules of both host and microbial origin, among which bile acids (BAs) hold profound importance.
Microbes convert host-derived primary bile acids into secondary bile acids, such as 7α-dehydroxylated
deoxycholic acid (DCA) and lithocholic acid (LCA), which constitute a significant part of the gut metabolome and
influence the chemical environment of the gastrointestinal lumen. In this proposed project, I will test the
hypothesis that cross-species metabolism is necessary to shape the bile acid pool that modulates the
structure and function of microbial communities in the gut. To test this hypothesis, I will focus on pathways
of 7α-dehydroxylation of bile acids, which create the most abundant secondary bile acids in humans and mice:
DCA and LCA. While the 7α-dehydroxylation of bile acids is attributed to bacteria encoding the bile acid-inducible
(bai) operon, our preliminary findings suggest an alternative mechanism in a microbial community devoid of the
bai. I hypothesize that a subset of this community orchestrates the 7α-dehydroxylation reaction through an
uncharacterized pathway involving polymicrobial cross-feeding of intermediates. Through combinatorial testing,
quantitative LC/MS methods, and comparative genomics approaches, we aim to elucidate the chemical
substrates and the microbial and genetic determinants necessary to complete this alternative polymicrobial
pathway. Furthermore, bacterial cross-feeding facilitates the chemical modifications of BAs that shift the overall
chemical property of the luminal space, which impacts the diversity and the ecology of the microbial community
in the gut. I will investigate this reciprocal relationship between bile acids and the microbiome by focusing on a
model opportunistic pathogen, Clostridiodes difficile. The effects of BA on C. difficile are multifaceted and
complex, and the role of the microbiome in modulating the chemical environment to inhibit C. difficile proliferation
is not fully understood. I will determine how shifts in the microbial composition in the gut and the subsequent
alteration in the bile acid metabolism impacts the growth of a single organism, C. difficile. Ultimately, a deeper
mechanistic understanding of microbial bile acid will significantly contribute to our knowledge of the origin of the
abundant bioactive and physiologically relevant metabolites in the gut. Moreover, it contributes to unraveling the
complex interplay between the chemical landscape and bacterial ecology in the gut to harness the microbiome
to combat pathogens and improve gut health.

Public health relevance
PROJECT NARRATIVE Cross-species metabolism by the microbiome determines the chemical landscape of the gastrointestinal tract profoundly influencing bacterial ecology in the gut. The proposed project will investigate the mechanisms of polymicrobial interactions that generate bioactive bile acids that discriminatively impact different organisms to exclude some commensal bacteria or opportunistic pathogens, such as Clostridiodes difficile. This work will aim to unravel complex microbe-microbe metabolic interactions with significant pathophysiological impact to host health.